PHAGE-ENABLED MINING OF GUT METAGENOMES FOR TERPENOID AND CAROTENOID METABOLISM

ABSTRACT
Terpenoids are the largest class of naturally occurring small molecules. While the majority of terpenoids originate
from plants and fungi, bacteria are also capable of producing them. Terpenoids are generated from sequential
additions of isoprene units, followed by derivatization via terpene synthase and cyclase enzymes. We have
analyzed Human Microbiome Project metagenomes using secondary metabolite prediction algorithms and found
that half of all human gut microbiomes carry at least one terpene biosynthetic pathway. We also recently
leveraged a high-throughput functional metagenomics approach and discovered that a histidine phosphatase
present in the human fecal microbiome without homology to known terpene synthases catalyzed the formation
of terpenoids. Carotenoids are mainly tetraterpenoids and are vitamin A precursors with important antioxidant,
immunological, and metabolic functions. The overall absorption efficiency of carotenoids can be quite low in the
small intestine; therefore, a significant quantity of carotenoids is transferred to the colon. When carotenoids enter
the colon, they can interact with the colonic epithelium by acting on biochemical pathways, as we have previously
shown. Despite this knowledge, how the gut microbiota might transform these compounds and how microbially
produced terpenes/carotenoids impact the gut lining are understudied. We have found that 93.3% of subjects
from the Human Microbiome Project contain carotenoid-modifying enzymes in their gut microbiota, and over half
of these subjects contain a terpene biosynthesis pathway. Other researchers have shown that a reduced
abundance of phytoene dehydrogenase in the gut microbiota is associated with symptomatic atherosclerosis,
and that gut bacteria synthesize retinoic acid to modulate host immunity. Carotenoids and their microbial
derivatives, therefore, have significant health impacts. In support of this, we have found that carotenoids in
carrots mitigated obesity-associated gut dysbiosis. Considering all this data, we hypothesize that the human gut
microbiome possesses yet-undiscovered terpene synthases and carotenoid modifying enzymes, and microbial
terpenoids/carotenoids can display immunomodulatory activities in the colon. To test these hypotheses, we first
will use a novel phage-based functional metagenomics approach and high-throughput screens to reveal terpene
synthases and carotenoid modifying enzymes. We then will conduct analytical chemistry experiments to
characterize the products of these enzymes. Finally, we will illustrate their biological activities in colon cells at
the immunological and proteomic levels. Taken together, this work will reveal new chemistry performed by the
gut microbiota and its effects on human health.

Public health relevance
PROJECT NARRATIVE Terpenoids and carotenoids are naturally occurring small molecules with diverse structures and a growing appreciation of their health impacts. Computer algorithms predict that human gut bacteria can produce these molecules, but their impacts on human health are unknown. This work will use high-throughput screening to reveal whether gut bacteria can make terpenoids and carotenoids, and measure their effects on human colon cells.